Light-propelled dental adhesives with enhanced bonding capability

Project Summary/Abstract:
The growing preference for aesthetically pleasing composite restorations is reflected in the over 122 million dental
restorations placed annually in the U.S. However, the replacement of failed restorations accounts for greater than 50% of
all restorative dental work. The relatively short duration composite restorations last in comparison to traditional restorations
(e.g., amalgam) is attributed to a weak hybrid layer, which is the layer that bonds the adhesive to the tooth structure. Bonding
to dentin in the tooth in a consistent and stable manner is challenging. While applying the adhesive resin on etched dentin,
relying on simple diffusion to homogenously infiltrate the dentinal tubules up to the etch depth in the presence of pulpal
pressure makes adhering to dentin less predictable and more technique sensitive. Leaving exposed collagen within the hybrid
layer compromises its mechanical strength and long-term stability by leaving it vulnerable to proteolytic degradation. We
propose a solution to this problem by introducing light-responsive, methacrylated nanoadditives that swell and disperse
within conventional adhesives and are designed to move away from a visible light source. By using light-induced resin
mobility, we propose to drive the controlled, light-activated, homogenous diffusion of hydrophobic and hydrophilic
adhesive resin components within dentinal tubules up to the depth of etching. This will ensure that the demineralized
surfaces and exposed collagen networks are now evenly and homogenously enveloped by resin within the hybrid layer to
form a mechanically robust anchor with the tooth. Subsequently, pendant functionality on the surface of the nanoadditives
will further enhance the strength of the resin-dentin interface and the stability of the collagen by introducing crosslinking
via primary and secondary bonds. The presence of labile functional groups that can induce intermolecular and
intermicrofibrillar collagen crosslinks, along with hydrophobic interactions can enhance the mechanical properties and
biostability of the adhesive layer. Increased crosslinking will also decrease the susceptibility of the hybrid layer to bacterial
collagenase and MMPs. Therefore, we will specifically aim to 1) synthesize 4 to 6 light-responsive nanoadditives that can
be incorporated within conventional adhesive resins and study adhesive resin propulsion as a function of 430-480 nm light
exposure, polymerization kinetics, degree of conversion, and mechanical properties under simulated pulpal pressure.
Toward this end, light-responsive nanoadditives will be synthesized using a solution polymerization protocol and the
adhesive resin-nanoadditive networks will be characterized based on the type and concentration of light-responsive moieties
within the networks. Pendant functionality introduced via nanoadditives to enhance bioadhesion and collagen crosslinking
will also be evaluated. In Aim 2, we will establish the conditions by which the nanoadditives can enhance bioadhesion
within the hybrid layer via additional crosslinking and characterize the µTBS, interfacial gap formation, and stability of the
resin-tooth interface in the oral physiochemical environment.

Public health relevance
Project Narrative The proposed research aims to address the compromised longevity and function of tooth-colored restorations in the oral cavity. Dubbed the ‘weakest link’ in a composite restoration, the mechanical strength, and stability of the adhesive layer that anchors the restoration to the tooth structure play a critical role in the overall performance and lifespan of the restoration. We propose the addition of novel light-propelled nanoadditives that can 1) drive the adhesive resin within the tooth structure to efficiently anchor the adhesive layer, and 2) enhance the adhesion of the resin-dentin interface and its stability by introducing additional crosslinks.